iDAPT: Implementation and Informatics - Developing Adaptable Processes and Technologies for Cancer Control

PROJECT SUMMARY
iDAPTs Administrative Core is responsible for the overall mission, leadership, and management of iDAPT:
Implementation and Informatics - Developing Adaptable Processes and Technologies for Cancer Control. The
Aims of the Administrative Core are to: (1) Create an organizational structure that fosters the successful
integration of the Research Program and Implementation Laboratory to advance implementation science in
cancer control with an emerging thematic focus on technology-supported interventions and implementation
processes; (2) Build the capacity of iDAPT laboratory partners to conduct implementation science research
aligned with iDAPT’s emerging theme; (3) Foster a culture of shared learning by bringing discoveries to the
Implementation Science Centers in Cancer Control (ISCCCs) while also sharing what is learned from the ISCCCs
with iDAPTs research and laboratory partners; (4) Ensure iDAPT is achieving milestones outlined within the
Research Program and Implementation Laboratory utilizing a robust and iterative evaluation and strategic
planning process. Core functions of the center include timely and bi-directional communication, engagement
with iDAPTs Research Program and Implementation Laboratory partners, measuring knowledge and practice
gaps that could be remediated by technology-supported interventions and strategies in primary care and
oncology clinics, reciprocal learning with the ISCCC network, and a stage-based, mixed methods implementation
monitoring plan. The Evaluation Unit will generate and analyze process-oriented data to assess progress and
improve practices of iDAPT and engage in a strategic planning initiative to understand more broadly the factors
that influence Center development and successes.